INCREASING DRUG DELIVERY INTO TUMORS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. A CAM model with brain and breast tumor spheroids will be utilized to study drug delivery. Photodynamic therapy will be used to increase vascular permeability and subsequent chemotherapy drug delivery to tumor spheroids. Molecular imaging of vasculature and tumor tissue architecture will be performed.